ELECTROPHYSIOLOGY AND PHARMACOLOGY OF MYOTONIC MUSCLE

The objective of this renewal application is to continue to investigate membrane mechanisms that underlie myotonia, a syndrome characterized by abnormal excitability leading to prolonged repetitive discharge of action potentials and abnormal contractions of skeletal muscle fibers. Electrophysiological and pharmacological methods will be used to study myotonic behavior of skeletal muscle fibers from myotonic goats and normal skeletal muscle of rats and frogs after induction of myotonia by chemical agents, ionic changes, or other treatments. Analysis will also be made of the action of drugs or of treatments such denervation which antagonize myotonia. Experiments will be made largely on biopsied muscle fiber bundles, single fibers or membrane vesicle preparations in vitro. The electrical measurements will include: membrane ionic currents and voltage dependent charge movement with a voltage clamp; membrane excitability and cable parameters with microelectrodes. The triple-vaseline-gap and the three-microelectrode voltage clamps will be used to monitor macroscopic ionic currents. Planar lipid bilayer and patch-clamp methods will be used to monitor single channel currents to answer questions concerning channel abnormalities. Extensive use will be made of the laboratory computer for analysis of these data and for testing of hypotheses through computer simulation of myotonic membrane behavior. Particular attention will be paid to the role of chloride conductance channels in the maintenance of normal excitability of skeletal muscle. The ultimate goals of this project are: 1) to increase our basic knowledge of the electrophysiological basis of myotonia to the level of membrane ionic channel function and 2) to provide rational bases for the control of myotonic syndromes in man.